Causes and consequences of microbe-mediated asexuality

Project Summary
Sexual reproduction evolved more than one billion years ago, shortly after the appearance of eukaryotes. Sex
is theorized to be an important aspect of creating genetic variation, adapting to new environments, and in
removing disadvantageous traits from the gene pool. Despite this, many eukaryotes have reverted to asexual
reproductive strategies. Importantly, such transitions to asexual reproduction have huge evolutionary impacts:
we see regular examples of this in the rapid spread of invasive, pathogenic, and drug-resistant organisms.
Unfortunately, such transitions are notoriously difficult to mechanistically interrogate due to their lack of
experimental tractability and the fact that many reversions to asexuality are quite ancient. However, arthropods
are rich in recently acquired vertically inherited microbes (e.g., Wolbachia, Rickettsia, and Cardinium) that
convert their arthropod hosts to asexual reproduction. So-called “parthenogenesis induction” has been
reinvented multiple times across these bacteria and relies on microbial mechanisms for impacting host meiosis
or mitosis to alter ploidy. We can manipulate these recently asexual lineages in the lab to mechanistically
define the cell biology of asexual reproduction. Furthermore, because there are numerous independent
transitions to microbe-mediated asexuality, and lineages will slowly undergo a loss of sexual function, we can
use this system to track the genomic and mechanistic consequences of lost sex. The long-term goal of my lab
is to link mechanistic processes of mitosis, meiosis, and reproduction to long-term organismal and genomic
consequences. This proposal describes my lab’s research goals across the next five years, which
include: (1) mechanistically characterizing bacterial proteins mediating asexual reproduction, (2)
identifying mitotic- and meiotic- effector proteins across diverse bacteria and reproductive biologies,
and (3) using forward genetics to map the genomic consequences of lost sex. Specifically, our creative
interdisciplinary research plan integrates genomic approaches (e.g., genome sequencing, comparative
genomics, quantitative trait loci mapping), molecular approaches in non-model organisms, and genetics in
tractable model systems (e.g., yeast, Drosophila). We will build on our recent discovery of the first putative
asexuality inducing bacterial effector proteins to broadly define how microbes have evolved to manipulate
mitosis and meiosis, and disentangle the causes of reproductive switches from the consequences. In addition
to the broad significance of reproduction, these systems afford new opportunities to understand fundamental
aspects of cell biology that underly many human-health relevant processes. For example, defects in mitosis
are typical of certain degenerative conditions and cancers, and changes in ploidy significantly contribute to
fungal pathogenesis and drug resistance. Our focus on novel mechanisms for altering reproduction and cell
division will support the development of new therapeutic avenues across a range of systems.

Public health relevance
Project Narrative Asexual reproduction has emerged many times across eukaryotes, but very little is known about the genetic mechanisms behind this major shift in biology. In addition to numerous pathogens that use asexual reproductive strategies, asexual reproduction serves as a key model for understanding the cell biology of meiosis and mitosis, and, processes such as cancer tumor evolution and fertility. The proposed research will leverage highly tractable insect systems in which microbial symbionts regulate reproductive mode to uncover the genetic basis of altered mitosis and meiosis and map the long-term evolutionary and genomic consequences of lost sex.